Development of a Clinically Relevant Genetically Engineered Mouse Model for Human High-Risk Rhabdomyosarcoma

PROJECT SUMMARY
The burgeoning field of cancer genomics has underscored the importance of genetically engineered mouse
models (GEMMs) in elucidating the complexities of human cancer. These models offer invaluable insights into
cancer drivers, cellular origins, heterogeneity, and therapeutic responses, bridging preclinical research and
clinical predictions. Rhabdomyosarcoma (RMS), the most prevalent soft tissue sarcoma in children, presents a
pressing clinical challenge with dismal prognosis rates, particularly in high-risk cases. Notably, aberrant
activation of the NOTCH1 pathway is implicated in 60% of human RMS cases, correlating with poorer survival
outcomes. Our overarching objective is to identify therapeutically relevant genetic factors and pathways that
impede RMS progression and to develop targeted therapies for sarcoma cancer. Central to this proposal is
exploring NOTCH1 pathway activation as both a driver and a therapeutic target in curbing RMS growth.
Leveraging our expertise in GEMM development, our study aims to create the first mouse models that faithfully
replicate key features of human RMS while also serving as platforms to evaluate Notch inhibition as a potential
cancer therapy. In pursuit of this goal, aim one focuses on developing and characterizing RMS mouse models,
including assessing drug effects on molecularly targeted agents that specifically modulate Notch activation, with
a particular emphasis on exploring synergistic effects of dual pathway inhibition. Aim two seeks to model Notch
inhibition as a targeted therapeutic approach in GEMMs. By integrating advanced molecular analyses with robust
in vivo models, our comprehensive approach holds promise for revolutionizing the clinical management of Notch-
driven RMS and other cancers with similar molecular profiles. Through this research, we seek to improve patient
outcomes, advance public health, and pave the way for transformative advancements in cancer therapeutics.

Public health relevance
PROJECT NARRATIVE Our research aims to develop novel mouse models of rhabdomyosarcoma (RMS) to understand this aggressive childhood cancer better and explore targeted therapies. By unraveling the role of the NOTCH1 pathway in RMS development and evaluating the effectiveness of Notch inhibition as a therapeutic strategy, we aim to improve treatment outcomes for patients with this devastating disease. This work has the potential to enhance our understanding of cancer biology and ultimately contribute to the development of more effective treatments, thereby reducing illness and disability associated with RMS and similar cancers.